Evaluating Policy Interventions to Decrease Excessive and Risky Perioperative Opioid Prescribing

PROJECT SUMMARY
At least 15.4 million opioid prescriptions in the United States are provided each year during surgical care.
Excessive and risky perioperative opioid prescribing patterns are common and increase the risk of opioid
overdose, addiction, diversion, and persistent opioid use. To mitigate these harms, policymakers and payers in
most states have enacted policies that restrict opioid prescribing for acute pain or mandate clinicians to review
prescription drug monitoring program databases before prescribing opioids (PDMP use mandates). To date, few
studies have rigorously assessed the intended and unintended effects of these policies in the context of surgical
care. In this 4-year study, we will use quasi-experimental methods to examine the impact of opioid prescribing
limits and PDMP use mandates on perioperative opioid prescribing, high-risk prescribing, opioid-related adverse
events, and patient-reported outcomes. First, we will use commercial, Medicare, and Medicaid claims databases
to evaluate the effect of state opioid prescribing limits and to assess variation in effects by policy feature, patient
population, procedure, and prescriber (Aim 1). Second, we will evaluate the effect of state PDMP use mandates
and examine heterogeneity in effects using the same claims databases (Aim 2). Finally, we will determine the
impact of a major Michigan insurer’s opioid prescribing limit and Michigan’s PDMP use mandate on opioid
prescribing and patient-reported outcomes after surgery, using a novel linkage between a statewide registry of
surgical patients and the state PDMP database (Aim 3). Our findings will directly inform efforts to mitigate
morbidity from perioperative opioid prescribing and close critical knowledge gaps needed to optimize future
policy design. For example, if opioid prescribing limits and PDMP use mandates have reduced perioperative
opioid prescribing with minimal unintended effects, policymakers should consider implementing these policies
more broadly. However, if the policies have not reduced perioperative opioid prescribing or have had substantial
unintended effects, other approaches may be needed. Ultimately, this proposal will contribute to the development
of well-designed policies that balance the need for safe opioid prescribing with the need for effective
postoperative pain management.

Public health relevance
PROJECT NARRATIVE At least 15.4 million opioid prescriptions in the United States are provided each year during surgical care, and many of these prescriptions are excessive or are written in a manner that increases the risk of opioid-related adverse events, such as overdose. To reduce these harms, policymakers and payers in most states have enacted policies that limit opioid prescribing for acute pain or mandate clinicians to review prescription drug monitoring program databases before prescribing opioids, but the effects of these policies on opioid prescribing, high-risk prescribing, opioid-related adverse events, and patient-reported outcomes among surgical patients are unknown. We will close these knowledge gaps using rigorous quasi-experimental methods, comprehensive medical claims from both privately and publicly insured adults, and data from a statewide Michigan surgical registry, thus revealing whether the policies should be expanded more broadly or whether other approaches are needed to mitigate the harms of perioperative opioid prescribing.